Impact of Sex on Glycosylation-dependent Antibody-mediated Innate Immune Functions During HIV Infection

PROJECT SUMMARY: Beyond neutralization, antibodies can elicit an array of Fc-mediated innate immune
functions such as antibody-dependent cell-mediated cytotoxicity (ADCC), antibody-dependent cellular
phagocytosis (ADCP), and antibody-dependent complement deposition (ADCD). These innate immune functions
are beneficial, as they contribute to pathogen clearance; however, they also can induce inflammation during viral
infections. Antibody glycosylation strongly impacts these functions. For example, fucose reduces ADCC, while
sialic acid and galactose are anti-inflammatory and may inhibit ADCP and ADCD. In our R01 AG062383, we
asked whether HIV infection during aging is associated with specific IgG glycomic alterations that persist despite
long-term antiretroviral therapy (ART). Our data show that antibodies from HIV+ ART+ individuals do indeed
exhibit specific glycomic alterations (loss of galactose and fucose) compared to antibodies from HIV-uninfected
counterparts in a manner linked to higher inflammation, enhanced ADCC/ADCP/ADCD, and higher incidence of
subclinical atherosclerosis. During this analysis, we noticed apparent differences between women and men.
During ART+ HIV infection, antibodies from women have a lower level of the anti-inflammatory and anti-
ADCP/ADCD sialic acid and galactose and higher levels of the anti-ADCC fucose compared to antibodies from
men. Biological sex has increasingly been recognized as an important modulator of immunity and disease
progression during HIV infection. However, the mechanisms underlying this phenomenon are unknown but
important to understand to design interventions that work for both sexes. These data support our hypothesis
that sex-dependent IgG glycomic dysregulation modulates Fc-mediated innate immune functions and
inflammation during ART-suppressed HIV infection. We will test this hypothesis with two aims:
In Aim 1, we will test the hypothesis that antibodies from women drive higher ADCP/ADCD, higher myeloid
inflammation, and lower ADCC than antibodies from men. We expect, based on their glycomic profile, that
antibodies from women will drive higher ADCP/ADCD, higher myeloid inflammation, and lower ADCC than
antibodies from men. We also expect that these differential abilities will be associated with higher inflammation
and inflammation-associated conditions. In Aim 2, we will test the hypothesis that glycoengineered IgGs from
women and men can modulate anti-HIV specific Fc-mediated innate immune functions and inflammation. We
recently implemented a method to chemo-enzymatically alter the glycosylation of antibodies. We will use this
method to alter the glycosylation of antibodies from men and women and test the ability of glycoengineered
antibodies to elicit specific innate immune functions and inflammation. We expect that antibodies with profiles
similar to those of women (low sialic acid/galactose) will elicit high ADCD/ADCP activities and inflammation. In
Summary, this supplement will identify novel glycomic and immunological pathways that can be modulated to
develop sex-aware/specific treatments that target immune functions and inflammation during aging with HIV.

Public health relevance
PROJECT NARRATIVE As HIV+ individuals age, they experience non-AIDS, inflammation-related illnesses, such as cardiovascular diseases, even when the virus is suppressed with antiretroviral therapy, in a manner different between women and men. The parent application of the supplement investigates whether the loss of specific anti-inflammatory circulating carbohydrate molecules (glycans) promotes the development of HIV-associated chronic inflammation. As we found that these glycan structures are indeed altered during HIV infection in a manner different by sex, this supplement will investigate whether these sex-based differences in the levels of these glycans promote different levels of inflammation in women and men living and aging with HIV.